Machine Learning Model Validation for AD/ADRD

PROJECT SUMMARY The primary goal of this Administrative Supplement is to study 20 candidate genes, previously not associated with Alzheimer's disease and related dementias (ADRD), in ADRD-relevant experimental models. These genes were identified by machine learning derived from meta-path-based protein knowledge graph integration. ADRD continues to be an intractable age-related neurodegenerative illness in elderly without a cure. Numerous clinical trials have failed in result in effective therapeutic management of ADRD. This unprecedented 99.6% failure rate in drug development targeting ADRD is, in part, due to lack of sufficient consideration of novel molecular pathways and mechanisms besides the ones neuropathologically associated with different dementias. The main thrust of this proposal is to use automated algorithmic network predictions based on the meta-path approach, by providing the integrated database developed at the Illuminating the Druggable Genome (IDG) Knowledge Management Center (KMC). Based on 13 distinct datasets totaling over 261 million datapoints, the AD-specific machine learning classifier model identified several key features, such as proteins that mediate inflammatory processes (JAK2, IL10 & IL2), response to oxidative stress (GSTP1), nervous system development (BDNF) and glycolysis (GAPDH). As a preliminary validation, we used human SHSY5Y cells that show robust hyper- phosphorylation of tau at S202 (itself a predictor of neurofibrillary tangle pathology relevant to ADRD) upon inflammatory stimuli (treated with cell supernatant from RAW macrophages). We used individual siRNA knockdown for the 20 predicted candidate genes in SHSY5Y cells prior to RAW macrophage media treatment, and assessed pS202-tau by Cellomics® unbiased high-content microscopy and quantitative morphometry. Four out of 20 candidate genes altered pS202 -tau levels in SHSY5Y cells, thus providing a proof-of-concept validation for the AD machine learning model. Based on this, we hypothesize that the AD-specific model is able to reliably identify novel biological datasets relevant to ADRD. We propose to test this hypothesis under three specific aims. In Aim 1, we will improve the meta-path machine-learning models and data mine novel associations. In Aim 2, we will perform in vitro biological validation for the top genes predicted by the meta-path approach. In Aim 3, we will build an interactive web platform to disseminate AD-gene associations. Successful completion of these studies will open up new avenues for ADRD research and may lead to novel therapeutic targets for ADRD.

Public health relevance
PROJECT NARRATIVE Given the discordance between neuropathological hallmarks of Alzheimer's disease and related dementias, ADRD, (e.g., amyloid beta pathology) and failed attempts to clinically manage ADRD therapeutically, there is an urgent need to identify novel drug targets. The Knowledge Management Center (KMC) for the Illuminating the Druggable Genome (IDG) program, to which this supplement is linked-to, plans to utilize its integrated database to develop machine learning models that can predict novel disease-protein associations. Specifically, a set of 20 genes not previously associated with ADRD, were predicted using machine learning. Of these, 4 genes show significant biological effects (regulating hyperphosphorylation of tau at S202) in ADRD-relevant cellular models. The goals of this administrative supplement are to enhance machine learning models, to provide biological validation of candidate genes predicted from machine learning, and to propose novel drug ADRD targets.